MECHANISMS RESPONSIBLE FOR GENOMIC INSTABILITY IN PREMATURE AGING LAMINOPATHIES

DESCRIPTION (provided by applicant): A-type lamins are intermediate filament proteins that provide a scaffold for tethering chromatin and protein complexes regulating nuclear structure and function. Interest in lamins increased after the association of mutations in the LMNA gene with a variety of degenerative disorders broadly termed laminopathies, cancer and aging. The causal relationship between alterations of A-type lamins and disease and the molecular pathways involved are poorly understood. Our data revealed novel functions for A-type lamins in the maintenance of telomeres and in the stabilization of 53BP1, a mediator in the DNA damage response pathway. Loss of A-type lamins leads to telomere shortening, telomeric chromatin defects, impaired DNA repair, increased genomic instability, and defects in the non-homologous end-joining of dysfunctional telomeres, a process that requires 53BP1. Some of these phenotypes would be consistent with 53BP1 deficiency. In support of this notion, reconstitution of 53BP1 into A-type lamins-deficient cells rescued defects in DNA repair. Elucidating molecular mechanism responsible for degradation of 53BP1 might provide novel targets for therapy. Our preliminary data indicates that 53BP1 is degraded by the protease Cathepsin L and by the proteasome. Interestingly, a mouse model of progeria (Zmpste24-/-) shown to markedly upregulate Cathepsin L, exhibits low levels of 53BP1, suggesting that deregulation of the Cathepsin L-mediated degradation of 53BP1 might be a common event in laminopathies. Importantly, we found that treatment with vitamin D, a known activator of Cystatin D [8], the endogenous inhibitor of Cathepsin L, rescues 53BP1 levels, providing a putative strategy to prevent 53BP1 degradation, ameliorating phenotypes of laminopathies. The hypothesis to be tested is that alterations in A-type lamins causing upregulation of Cathepsin L lead to destabilization of 53BP1 protein and defects in DNA repair and telomere stability, contributing to genomic instability and the phenotypes of some lamin-related diseases. Our hypothesis will be tested under three specific aims. Under Aim 1, we will elucidate the molecular mechanisms leading to destabilization of 53BP1 in laminopathies and evaluate ways to target this pathway and improve DNA repair. Under Aim 2, we will determine the extent to which deregulation of the Cathepsin L/53BP1 pathway in laminopathies affects telomere stability. Under Aim 3, we will determine whether regulation of the Cathepsin L/53BP1 pathway by vitamin D ameliorates the pathophysiology of lamin-related diseases in vivo. The studies performed here will be of significance not only for elucidating the molecular mechanisms by which A-type lamins impact on telomere function and DNA repair, but also for understanding the underlying basis of the pathophysiology of lamin-related diseases, including degenerative laminopathies, premature aging syndromes and cancer. The results of our study could translate into the development of novel therapeutic strategies that target 53BP1 degradation pathway to improve the phenotypes associated to these diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: Understanding the cellular functions of A-type lamins, structural components of the nucleus, has become a highly topical subject due to their implication in a number of degenerative disorders broadly named laminopathies, as well as in cancer and aging. The molecular pathways by which defects in A-type lamins contribute to disease are poorly understood. Genomic instability caused by defective repair of DNA damage has been proposed to contribute to the pathogenesis of laminopathies. This proposal aims to unravel molecular mechanisms that are altered upon loss of A-type lamins leading to increased genomic instability. In addition, we will evaluate ways to target these molecular mechanisms with the goal of identifying treatments that ameliorate the phenotypes of laminopathies. Both, studies with primary cells (in vitro) and with mouse models of laminopathies (in vivo) will be conducted. The knowledge obtained from this research will be of great possible significance for the development of therapeutic approaches to treat lamin-related diseases. RELEVANCE: Understanding the cellular functions of A-type lamins, structural components of the nucleus, has become a highly topical subject due to their implication in a number of degenerative disorders broadly named laminopathies, as well as in cancer and aging. The molecular pathways by which defects in A-type lamins contribute to disease are poorly understood. Genomic instability caused by defective repair of DNA damage has been proposed to contribute to the pathogenesis of laminopathies. This proposal aims to unravel molecular mechanisms that are altered upon loss of A-type lamins leading to increased genomic instability. In addition, we will evaluate ways to target these molecular mechanisms with the goal of identifying treatments that ameliorate the phenotypes of laminopathies. Both, studies with primary cells (in vitro) and with mouse models of laminopathies (in vivo) will be conducted. The knowledge obtained from this research will be of great possible significance for the development of therapeutic approaches to treat lamin-related diseases. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The central hypothesis to be tested is that deregulation of mechanisms controlling the stability of 53BP1 induces genomic instability and contributes to the pathophysiology of some lamin-related diseases. Alterations of A-type lamins are associated with degenerative disorders and premature aging syndromes, termed laminopathies, as well as physiological aging and cancer [1-3]. The available data about the consequences of alterations of A-type lamins come from studies of patients with progeria (HGPS) and from mouse models of laminopathies, especially Zmpste24-/-, which exhibit a progeria phenotype, and Lmna-/- [4-6]. The molecular pathways by which defects in A-type lamins contribute to disease are poorly understood. Genomic instability caused by defective repair of DNA damage has been proposed to contribute to the pathogenesis of laminopathies. Our studies in Lmna-/- fibroblasts show that loss of A-type lamins impacts on telomere stability and DNA repair, in part due to destabilization of 53BP1, a mediator of the DNA damage response (DDR) pathway [7]. Accordingly, reconstitution of 53BP1 levels rescues defects in DNA repair in Lmna-/- cells. We also found that the cysteine protease Cathepsin L and the proteasome participate in the degradation of 53BP1. Interestingly, Cathepsin L is markedly upregulated in Zmpste24-/- cells [5] concomitant with a decrease in 53BP1 levels (our results). Thus, the Cathepsin L degradation pathway might represent a therapeutic target for laminopathies. Interestingly, our preliminary data shows that treatment with vitamin D, a known activator of Cystatin D [8], the endogenous inhibitor of Cathepsin L, rescues 53BP1 levels, providing a putative strategy to prevent 53BP1 degradation, ameliorating phenotypes of laminopathies. The specific hypothesis to be tested in this proposal is that alterations in A-type lamins causing upregulation of Cathepsin L lead to destabilization of 53BP1 protein and defects in DNA repair (aim 1) and telomere stability (aim 2), contributing to genomic instability and the pathophysiology of some lamin-related diseases (aim 3). Aim 1. Elucidate molecular mechanisms leading to destabilization of 53BP1 in laminopathies and evaluate ways to target this pathway and improve DNA repair. Rationale: Lmna-/- fibroblasts exhibit low levels of 53BP1 and defective DNA repair, a phenotype that is rescued by reconstitution of 53BP1 levels. The molecular mechanisms responsible for regulating 53BP1 levels are unknown. Our studies indicate that 53BP1 levels are stabilized by inhibitors of Cathepsin L and the proteasome. Interestingly, Zmpste24-/- fibroblasts exhibit a pronounced upregulation of Cathepsin L, low 53BP1 levels, defects in DNA repair, and increased genomic instability [5, 9]. These findings suggest that inhibitors of Cathepsin L could improve DNA repair in 53BP1-deficient cells. Hypothesis: Upregulation of Cathepsin L leads to decreased levels of 53BP1 and defects in DNA repair, contributing to the genomic instability of progeria and putatively other laminopathies. Approach: We propose to determine (a) the molecular mechanism of 53BP1 degradation, and its regulation; (b) whether targeting the Cathepsin L-mediated 53BP1 degradation pathway in Zmpste24-/- and Lmna-/- fibroblasts ameliorates defects in DNA repair. Aim 2. Determine the extent to which deregulation of the Cathepsin L/53BP1 pathway in laminopathies affects telomere stability. Rationale: 53BP1 promotes NHEJ, represses spontaneous recombination, and aids in the recruitment of proteins to stalled replication forks [10, 11]. We found that 53BP1 binds to both functional and dysfunctional telomeres. Lmna-/- fibroblasts exhibit aberrant recombination events involving telomeres, increased telomere loss, and defective NHEJ of dysfunctional telomeres [7]. Zmpste24-/- fibroblasts also exhibit telomere losses, with no evidence of chromosome end-to-end fusions. The associated decrease in 53BP1 in these mouse models could contribute to these telomere phenotypes, providing a second source of genomic instability in laminopathies. Hypothesis: 53BP1 plays a role in telomere replication, recombination, and repair, so that deregulation of the Cathepsin L/53BP1 pathway impacts telomere stability. Approach: We propose to determine (a) whether 53BP1 plays a role in telomere replication/recombination; (b) the functional relationship between A-type lamins and 53BP1 during NHEJ of dysfunctional telomeres; and (c) if targeting the Cathepsin L/53BP1 pathway improves telomere defects in Lmna-/- and Zmpste24-/- fibroblasts. Aim 3. Determine whether regulation of the Cathepsin L/53BP1 pathway by vitamin D ameliorates the pathophysiology of lamin-related diseases. Rationale: Inhibitors of prenylation -statins and aminobisphosphonates- considerably improve nuclear morphology and DNA damage in HGPS and Zmpste24-/- fibroblasts, primarily by reducing the prenylated toxic form of lamin A [12]. These inhibitors might restore normal levels of Cathepsin L and 53BP1, improving DNA repair and telomere stability. Hypothesis: Combined treatment with vitamin D and prenylation inhibitors impacts on the Cathepsin L/53BP1 pathway and ameliorates the phenotypes of laminopathies. Approach: We propose to (a) determine whether treatment with prenylation inhibitors impacts on the Cathepsin L/53BP1 pathway; (b) test if treatment with vitamin D in combination with prenylation inhibitors ameliorates the phenotypes of Zmpste24-/- mice.